Comprehensive Systematic Evidence Review of the Clinical Utility of Polygenic Risk Scores for Hepatocellular Carcinoma and Pancreatic Cancer Risk Assessment

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-046. Hepatocellular carcinoma (HCC) and pancreatic cancer, as leading causes of cancer-related mortality
in the United States, urgently necessitate effective early detection and prevention strategies to transform patient
outcomes. The advent of polygenic risk scores (PRS) in genetic research represents a groundbreaking
opportunity to refine risk assessment and clinical management for HCC and pancreatic cancer. This project will
conduct a state-of-the-science systematic evidence review to critically examine the clinical utility of PRS for these
malignancies, providing a solid foundation for informed decision-making in clinical practice. Our multidisciplinary
team, boasting extensive expertise in systematic reviews and a diverse array of fields—biomedical informatics,
biostatistics, statistical genetics, cancer epidemiology, clinical trials design, oncology, and cancer control—will
rigorously apply established knowledge synthesis guidelines to execute the proposed supplement. This
meticulous approach will enable us to identify PRS models poised for clinical trials, evaluate their limitations and
challenges, and determine their clinical utility. Furthermore, we will assess the potential benefits and harms of
PRS implementation in clinical practice, explore innovative strategies to integrate PRS with non-PRS models for
enhanced cancer risk prediction and propose optimal study designs and methodologies for evaluating PRS
efficacy and effectiveness. Our robust framework for conducting this comprehensive systematic evidence review
comprises five essential steps: 1) framing the questions, 2) identifying relevant work, 3) assessing the quality of
studies, 4) summarizing the evidence, and 5) interpreting the findings. Our comprehensive search strategy will
encompass major biomedical and health sciences electronic databases, the grey literature, and online PRS
repositories, ensuring a thorough analysis. Employing the Prediction Model Risk of Bias (ROB) Assessment Tool
(PROBAST), we will rigorously assess reviewed studies’ qualities and applicability. Upon completion, this project
will generate indispensable evidence on the potential benefits, harms, and clinical utility of PRS implementation
for HCC and pancreatic cancer risk assessments. Our findings will inform recommendations for future research
directions and contribute to developing evidence-based guidelines for PRS use in cancer prevention, early
detection, and management, ultimately leading to improved patient outcomes in a new era of personalized
cancer care.

Public health relevance
Project Narrative This supplement seeks to evaluate the clinical utility of polygenic risk scores (PRS) for hepatocellular carcinoma and pancreatic cancer, with the goal of informing risk assessment and clinical management. Our multidisciplinary team will systematically review PRS models, assess their limitations, and explore their integration with non-PRS models for improved cancer risk predictions. The outcomes of this research will pave the way for evidence-based guidelines and recommendations, ultimately contributing to improved patient outcomes and reduced cancer-related morbidity and mortality.